Glucagon and insulin act cooperatively in the regulation of prandial hepatic glycogen metabolism

Project Summary
Glucagon and insulin are pancreatic hormones that control the glycemic response to fasting and feeding.
Canonically, glucagon is secreted in the fasted state where it stimulates hepatic glycogenolysis and
gluconeogenesis in order to raise glycemia. Conversely, insulin is secreted in response to elevated blood glucose
to stimulate glucose uptake in peripheral tissues. These canonical, opposing effects of glucagon and insulin on
the liver overlook the long understanding that amino acids in mixed nutrient feeding stimulate the islet a-cell to
secrete glucagon. Moreover, our recent work has shown the importance of glucagon-stimulated insulin secretion
to maintaining glucose tolerance. Therefore, the expected response to a physiologic mixed nutrient meal is the
co-secretion of glucagon and insulin into portal circulation. The preliminary data presented herein support the
notion that glucagon and insulin work cooperatively, not antagonistically, to control prandial glucose metabolism.
We hypothesize that glucagon and insulin co-secretion controls hepatic glucose metabolism to allow glucose to
reach the periphery before being stored in the liver. Successful completion of this project will alter our
fundamental understanding of hepatic glucose metabolism and my provide insight for novel therapeutic targets
for the treatment of metabolic disease. Importantly, completion of the proposed aims will support several new
technical and conceptual developments that will provide a foundation for a career as an independent investigator.

Public health relevance
PROJECT NARRATIVE Glucagon and insulin are considered to be opposing factors for regulating glucose metabolism, yet they are co- secreted in response to a mixed nutrient meal. Our preliminary data suggests that glucagon and insulin coordinate, rather than oppose, each other to regulate hepatic glycogen metabolism. In this proposal, we will test the hypothesis that glucagon and insulin generate a unique hepatic signature that leads to optimal systemic glucose utilization.